New insights into extracellular signal transduction

PROJECT SUMMARY
One of the most fundamental properties of cells is the ability to transduce signals to other
cells and the surrounding environment. Well recognized modes of cellular signaling include direct
cell-cell interactions via membrane receptors and ligands and the release of soluble factors, such
as growth factors, cytokines and chemokines. The more recently described extracellular vesicle
(EV) is now also considered as an important mediator of cell signaling, allowing cells to exchange
proteins, lipids and genetic material. EVs are secreted from nearly all cell types and EV-based
communication relies on the ability of vesicles to deliver bioactive molecules to other cells. The
field of EV biology is rapidly evolving and expanding, affecting almost all biomedical disciplines,
from oncology and obstetrics to infectious diseases and stem cell biology. Cells release EVs not
only in culture but also in vivo, and diverse types of vesicles have been isolated and analyzed
from almost all bodily fluids, leading to the postulation that EV-based liquid biopsies can be used
for diagnostics. However, despite the excitement and hundreds of new publications on EVs in
recent past, several basic hypotheses regarding their function remain experimentally untested. A
major challenge in EV research is the huge and often underappreciated diversity in shed vesicles.
Many of the impediments to advance EV biology and application, stem from the inability to
separate a complex population of vesicles into subclasses of particular sizes, compositions, and
biogenesis pathways. Microvesicles (MVs) are an EV subtype which are shed by the direct
outward budding of the plasma membrane. They are present in biological fluids and appear to be
involved in multiple physiological and pathological processes. However, much remains unknown
regarding the biogenesis and role of these vesicles as signaling mediators. Here we propose
strategies to catalog molecular cargoes targeted specifically to MVs and identify new regulators
of cargo loading. We also aim to interrogate GTPase-regulated cell signaling pathways that
regulate MV release. Finally, we will examine the interactions of MVs with receptors on endothelial
cells and consequent signaling pathways activated in the recipient cell. These studies will provide
new insights into a rapidly evolving frontier in signal transduction, as well as the molecular basis
of various diseases.

Public health relevance
PROJECT NARRATIVE Microvesicles are small membrane enclosed sacs shed by all cells types and a growing body of evidence implicates these vesicles as a novel mode of intercellular signaling not only in normal physiology but also in several pathophysiological processes. However, we only have a rudimentary understanding about the cellular cues that drive their biogenesis and function. By investigating the composition of MVs, mechanisms involved in their release, interaction with target cells we expect to gain new insights into MV biology that in turn will inform new therapeutic strategies for diseases such as cancer, diabetes, neurodegenerative disease and cardiovascular disorders.